Diversity Supplement for R37 Grant

Summary/Abstract
This proposal is for a Diversity Supplement to R37CA273232 to support a graduate student
Benjamin Kroger. Below is the abstract for the parent award, and as part of this diversity
supplement, Mr. Kroger will be contributing to studies performing ribosome proﬁling to
identify key LSC regulators selectively translated in the context of regulated protein
synthesis.
Leukemia stem cells (LSCs) promote therapeutic resistance and poor clinical outcomes in
acute myeloid leukemia (AML). Central to the function of LSCs is a capacity for aberrant
self-renewal, but the mechanisms underlying this activity are not well understood. The
long-term goal is to identify these mechanisms to develop new therapies that can eradicate
LSCs to improve clinical outcomes. The overall objectives in this application are to (i)
determine if LSCs from speciﬁc genetic subtypes of AML are dependent on regulation of
protein synthesis, (ii) determine whether LSCs in high-risk hematopoietic stem cell (HSC)-
like AMLs are more dependent on regulated protein synthesis, and (iii) test a novel
therapeutic strategy inhibiting protein synthesis in LSCs. The central hypothesis is that
LSCs aberrantly self-renew by adopting from normal HSCs a dependence on tightly
regulated protein synthesis. The rationale for this project is based on the ﬁnding that the
cell surface marker CD99 is selectively overexpressed on LSCs and serves to regulate
protein synthesis to promote LSC function. This offers a strong scientiﬁc framework by
which new strategies to deplete LSCs can be developed. The central hypothesis will be
tested by pursuing three speciﬁc aims: 1) Determining the role of regulated protein
synthesis in promoting LSC function; 2) Determining if the cell-of-origin of AML inﬂuences
the dependence of LSCs on regulated protein synthesis; and 3) Determining if inhibition of
protein synthesis can deplete LSCs in high-risk AML. In the ﬁrst aim, genetically engineered
mice will be used to generate models of AML lacking CD99, to test if this leads to
dysregulated protein synthesis that impairs LSC self-renewal. LSCs from these models will
be evaluated to determine if they require low protein synthesis rates to prevent induction of
tumor suppressors, the unfolded protein response, and the integrated stress response.
Ribosome proﬁling will be performed to identify key LSC regulators selectively translated in
the context of regulated protein synthesis. In the second aim, we will generate a mouse
model of HSC-like AML which mimics high-risk human AML. We will assess if LSCs in HSC-
like AML exhibit heightened sensitivity to dysregulated protein synthesis. These studies will
be complemented with an evaluation of protein synthesis in HSC-like human LSCs to
determine if they also require maintenance of low levels of protein synthesis. The third aim
will test if the combination of a ribosome biogenesis-inhibitor with a BCL2-inhibitor
currently used to treat AML can eradicate LSCs in high-risk HSC-like AML. The proposal is
innovative, in the applicant’s opinion, because it aims to leverage a novel LSC-speciﬁc cell
surface marker to establish a new paradigm for understanding mechanisms underlying
LSC self-renewal. The proposed research is signiﬁcant because it is expected to provide a
strong scientiﬁc justiﬁcation for the development of therapies inhibiting protein synthesis
to overcome therapeutic resistance in patients with high-risk AML. Ultimately, the
knowledge gained from these studies may offer insights into the mechanisms that promote
the function of cancer stem cells in general, opening up opportunities for the development
of new strategies to treat cancer.

Public health relevance
Narrative Leukemia stem cells are responsible for poor clinical outcomes in patients with acute myeloid leukemia, and the proposed research addresses a need to better understand the mechanisms that underlie their function. We recently discovered that the cell surface marker CD99 promotes leukemia stem cell self-renewal by constraining protein synthesis, establishing a new link between regulated protein synthesis and leukemia stem cell function. By elucidating the mechanisms underlying why leukemia stem cells depend on regulation of protein synthesis across different subtypes of acute myeloid leukemia, this project has the potential to establish a new paradigm for how cancer stem cells sustain themselves, as well as to guide the design of more effective therapies targeting leukemia stem cells to improve clinical outcomes for patients with acute myeloid leukemia.